Targeting Arc to Improve Cognitive Deficits in Psychotic Disorders

PROJECT SUMMARY
The degree of cognitive impairment is the best predictor of functional outcomes in schizophrenia, but the
efficacious treatment of these deficits remains a significant challenge. Genome-wide association and exome
sequencing studies point to an essential role for components of the Arc protein complex in glutamatergic
dysregulation in schizophrenia. Studies of synaptic plasticity and memory consolidation suggest that loss of Arc
function may be important in the pathophysiology of cognitive impairments in multiple neuropsychiatric disorders.
These results indicate that targeting Arc may provide a new avenue to improve cognitive impairments in these
disease contexts. To explore the feasibility of this objective, we carried out a high-throughput, image-based
screen in mouse cortical neurons to identify small molecules that potentiated neuronal activity-dependent
induction of Arc at the mRNA and protein level. One of the strongest enhancers of Arc expression was an atypical
antipsychotic, lurasidone, whereas many other antipsychotics were inactive. Consistent with the potential unique
properties of lurasidone, human clinical studies suggest that lurasidone can improve cognitive performance in
schizophrenia. Moreover, in preclinical behavioral studies, lurasidone ameliorates the learning and memory
impairment induced by the NMDA receptor antagonist MK-801. Based on these observations, we hypothesize
that differential modulation of Arc in cortical glutamatergic neurons by lurasidone is the basis for its
pro-cognitive effects. We will test this hypothesis by first deriving a quantitative structure-activity relationship
that allows for the optimization of Arc enhancement using our chemical synthesis and high-content neuronal
imaging platform. Building on our strong preliminary data demonstrating the conservation of lurasidone’s
enhancement of Arc expression in human iPSC-derived cortical neurons and lurasidone’s ability to increase
dendritic spine density deficits in these neurons, we will profile a focused collection of lurasidone derivatives with
strong preliminary data demonstrating the feasibility of successfully doing so. To extend this functional
characterization, we will use cerebral organoids from existing schizophrenia and matched healthy iPSCs to
determine their response to Arc-enhancing compounds at the level of single-cell transcriptomes, dendritic spine
density, and electrophysiological profiles using multielectrode array technology. Finally, to connect to clinical
studies, systematic characterization of iPSC-derived neurons from our existing cohort of first-episode
schizophrenia patients who show significant cognitive improvement with lurasidone compared to patients who
are lurasidone non-responders will be performed to provide mechanistic insights into Arc and cellular phenotypes
that correlate with cognitive enhancement and differential patient response. Successful completion of these
studies will result in a more precise understanding of the role of Arc in neuroplasticity, provide novel
pharmacological probes, and create a unique collection of iPSC models from first-episode psychosis patients
that can be used to probe the neural substrates underlying cognitive deficits and lurasidone treatment response.

Public health relevance
PROJECT NARRATIVE Even though cognitive deficits in schizophrenia and related psychotic disorders have an enormous impact on human health and disability, many patients do not show any cognitive improvement with current antipsychotic medications. Thus, there exists an urgent need to develop insight into the neural substrates and neuroplasticity mechanisms underlying cognition and the discovery of novel antipsychotic medications with the potential to lead to cognitive improvement. This proposal uses innovative, patient-derived iPSC and cerebral organoid techniques to ask mechanistic questions concerning the role of Arc-dependent neuroplasticity in psychotic disorders using high-resolution imaging and functional genomic methods in concert with parallel analysis of clinical outcomes of first-episode psychosis patients treated with lurasidone; it is likely to be of high impact because it focuses on human disease neurobiology in relation to the early stage of psychosis and cognitive deficits in schizophrenia, thereby helping lay a foundation for advancing precision medicine.